Assessing the impact of floods and federal policies on older adult mortality:leveraging Bayesian, quasi-experimental, and agent-based modelingtechniques

ABSTRACT
Floods account for the majority of global climate change-attributable deaths in the 21st century and are predicted
to increase substantially as the climate continues to rapidly change. As such, the health toll of ﬂoods stands to
increase and will disproportionately affect the most vulnerable populations – particularly older adults. Older adults
face heightened ﬂood vulnerability due to disproportionate residence in ﬂoodplains, frailty, diminished hearing and
vision, pre-existing chronic conditions, reliance on electricity-dependent medical equipment, and dependence on
healthcare access. Thus, identifying policies to safeguard older adults' health during and following ﬂoods is
paramount. In the US, the Federal Emergency Management Agency (FEMA) is tasked with prevention and
mitigation of the effects of climate disasters. Two programs that are particularly important in the relief efforts
from ﬂood events are FEMA's National Flood Insurance Program (NFIP) and the Individuals and Households
Program (IHP). These programs provide resources and services to individuals before, during, and after climate
disasters – including major ﬂoods. As the rate of ﬂoods dramatically increases, understanding the ways in which
ﬂoods affect mortality and these programs stand to buffer those effects is paramount. A critical research gap
remains about (1) the effects of these FEMA programs on health, and (2) how long major ﬂoods may affect health
beyond the initial days. This project will examine the effect of these programs on all-cause mortality among older
adults, and will estimate both the short- and long-term effects of ﬂoods on all-cause, cardiorespiratory, and injury-
related mortality at various time lags. Our overarching hypothesis is that ﬂoods affect health for up to a year
following a major ﬂood and that programs such as NFIP and IHP mitigate these effects. To test this hypothesis,
we aim to (1) estimate the effect of NFIP availability on ZCTA-level mortality among Medicare enrollees after
major ﬂoods and use an agent-based model to simulate NFIP mortality beneﬁts, (2) estimate the effect of FEMA
IHP application approval rate on mortality among Medicare enrollees after major ﬂood exposure and use an
agent-based model to simulate IHP mortality beneﬁts, and (3) assess the relationship between exposure to
major ﬂoods and all-cause, cardiorespiratory, and injury-related mortality at the county level in the short- and
long-term. The proposed research includes a high-quality training plan that includes academic and scientiﬁc
support for the success of the applicant in demographic methods, epidemiologic methods, causal inference and
quasi-experimental design, climate epidemiology, Bayesian methods, agent-based modeling, and professional
development. All of the proposed research will be supported by an interdisciplinary team and environment at the
University of Washington. Collectively, the project will provide evidence that can inform future climate adaptation
and FEMA policies to reduce preventable ﬂood-attributable mortality.

Public health relevance
PROJECT NARRATIVE This project aligns with NIA’s strategic plan by assessing policy-relevant factors that can enhance older adults’ resilience in the face of climate change. We plan to examine the role of Federal Emergency Management Agency (FEMA) programs in the relationship between major floods and mortality and the short- and long-term effects of floods on mortality. Our project can shape approaches to minimize flood-attributable mortality, especially among vulnerable older adults, and to inform FEMA preparedness strategies, emergency response, and resource allocation.